Cancer Genomics Research Laboratory

NCI's Advanced Technology Center (ATC), established for the implementation of novel technologies to address biological, clinical, and genetic questions pertinent to human cancers, includes the Cancer Genomics Research Laboratory, which is overseen by DCEG. The LTG is adjacent to the CGR and consists of three principal investigators and their respective laboratories, which work closely with the expertise in the CGR and DCEG. The aim of the CGR is to meet the genotyping and selected DNA sequencing needs of the DCEG and NCI's Center for Cancer Research. The facility performs high-throughput genotyping and sequencing to support genetic analysis for a broad range of projects for the intramural research program of the NCI. Working in concert with epidemiologists, biostatisticians and basic research scientists in the intramural research program, the CGR has developed the capacity to conduct genome-wide association studies and candidate gene approaches to identify the heritable determinants of various forms of cancer. The Cancer Genomics Research Laboratory(CGR) offers a wide variety of sample preparation and genotyping operations. All samples received must meet minimum requirements and are taken through the Sample Handling pipeline prior to completing any genotyping. The Sample Handling pipeline includes DNA quantification and genetic fingerprinting. Also offered is current Whole Genome Amplification (WGA) technology designed to increase available DNA from samples with minimal residual DNA. The genotyping platforms cover a wide-range of size and scope. The CGR operates the Illumina© BeadLab system which supports Illumina assay technologies including the whole genome genotyping Infinium© assays, custom GoldenGate© OPA assays, and Custom Infinium© (iSelect©) assays. The CGF operates next generation sequencing with two 454/Roche instruments with high throughput analytical capacity for targeted regions identified in GWAS and linkage studies. In addition, the CGR offers Affymetrix© GeneChip© arrays and uniplex TaqMan© genotyping. Informatics at the CGR is focused on two main areas: Information Management, the electronic storage and retrieval of data, and Analytics, the employment of the most appropriate statistical methods to effectively and accurately draw conclusions from the data generated by the laboratory.